Targeted Probiotic Yeast for Treating Inflammatory Bowel Diseases

Project Summary
Inflammatory bowel disease (IBD), which includes Crohn's disease and ulcerative colitis, are chronic, relapsing-
remitting conditions that affect more than 1.6 million adults and 80,000 children in the US alone. Patients suffer
from severe abdominal pain with bloody diarrhea caused by chronic inflammation and ulcer formation in the
gastrointestinal tract. Current therapies provide only symptomatic relief, with 25% of IBD patients requiring
hospitalization and 45% relapsing. Many of the drugs administered cause severe side-effects. We hypothesize
that an orally administered nanobiologic secreted by a bioengineered yeast therapeutic, capable of (a) reducing
the inflammatory response and (b) modulating the gut microbiome, will offer a safer and more effective treatment
for IBD. To test this hypothesis, we will design, characterize and optimize fibronectin-targeting, nanobody drug-
secreting S. boulardii as a function of S. boulardii proliferation and fibronectin density through a stable and
dynamic ligand expression system (Aim 1). In Aim 2 we will determine the pharmacokinetics, colon retention,
immunogenicity, and biodistribution of the dynamic and stable ulcer-targeting, nanobody drug-secreting S.
boulardii. We will use physiologically-based computational modeling to guide dosing regimens. Aim 3 of the
study involves evaluating the therapeutic effectiveness of S. boulardii and its potential to modulate the host
microbiome in mouse models of ulcerative colitis. Specifically, one of the sub-tasks will involve the use of a
human microbiota-associated IBD mouse model. This newly developed approach will be utilized to assess how
engineered S. boulardii may alter a human IBD-associated microbiome. Our studies will advance targeted
microbial therapeutics and oral nanobiologics towards the clinic to improve outcomes for ulcerative colitis
patients. Here we combine pharmacoengineering, computational modeling, pharmacokinetics studies, and
microbiome analysis to develop highly integrated, microbe-based therapeutics. We expect that the outcome of
these studies will yield new strategies for IBD therapy that will be relevant to other diseases that affect the
gastrointestinal tract or other ulcerative conditions.

Public health relevance
PROJECT NARRATIVE We have developed a novel therapeutic based on engineered probiotic yeast to treat inflammatory bowel diseases. This new type of drug is designed for oral administration to directly act at the disease site while reducing systemic side effects associated with many currently available treatment options. Our studies are expected to advance targeted microbial therapeutics towards the clinic to improve outcomes for patients with inflammatory bowel diseases.